TCR signaling strength regulated T cell differentiation during chronic viral infection

Summary
Although it is becoming increasingly clear that CD8 T cells responding to chronic infection are phenotypically
and functionally diverse, little is known about how to overcome T cell exhaustion to treat infectious diseases.
Using single cell RNA sequencing (scRNA-seq), the investigator's team has confirmed the presence of
previously identified TCF-1hi progenitor and PD-1hi exhausted T subsets. Surprisingly, they also found a
CX3CR1+ effector subset at the late phase of chronic infection. More importantly, they have shown that
CX3CR1+ effector cell formation is critically dependent on IL-21-producing CD4 helper T cells. The discovery of
this potent antiviral effector subset provides new opportunities for therapeutic interventions to treat infectious
diseases. To better understand the genesis of CX3CR1+ effector cells, the investigator's team proposes to use
the newly developed technology of paired single-cell RNA and TCR sequencing (scTCR-seq) to “lineage trace”
back to the ancestors (progenitors) of effector and exhausted cells. Their preliminary data suggest that TCR
signaling strengths positively correlate with exhausted T cell subset differentiation, but negatively correlate with
effector T cell differentiation. In parallel, they also provide evidence that CX3CR1+ effector cell formation
depends on cross-presenting dendritic cells (DCs), especially Batf3+ XCR1+ cDC1s. These cDC1 cells are
likely subjected to CD40-mediated CD4 helper T cell licensing, which is unexpected in the context of persistent
infection and possibly occurs in specialized cellular structures. Taken together, the investigator hypothesizes
that progenitor CD8 T cells need to be primed and activated by the cDC1s again at the late phase of chronic
infection to enter into a proliferative burst as a transitory differentiation state, and then bifurcate into two
terminally differentiated subsets: CX3CR1+ effector and PD-1hi exhausted CD8 T cells. Mechanistically, CD4 T
cells need to provide signals to license DCs for their cross-presentation, and TCR signaling strength dictates
the threshold of progenitor cell activation and influences the effector versus exhausted cell fate choice.
Harnessing this knowledge, they intend to alter the course of T cell differentiation by changing TCR signaling
strength through identification and validation of TCR signaling negative regulators (TSNRs) that can be
exploited to favor the formation of CX3CR1+ effector T cells for improved viral control. The investigator's team
will test these hypotheses in the following three aims. First, they will use paired scRNA- and scTCR- seq and
associated computational tools and biological validations to delineate virus-specific CD8+ T cell differentiation
trajectories and dissect how TCR signaling strength affects cell fate decisions. Second, they will use genetic
models to delineate the mechanisms by which DCs are licensed by CD4 helper T cells for CD8 T cell priming
and differentiation. Third, they will employ high-throughput targeted CRISPR screen and gene editing to test if
manipulating TCR signaling strength can redirect CD8 T cells towards effector differentiation and overcome
exhaustion to treat chronic infection and cancer.

Public health relevance
Narrative Successful control of chronic viruses, such as HIV and HCV, greatly depends on vigorous and well-coordinated CD4+ and CD8+ T cell responses. This study aims to identify cellular and molecular mechanisms, as well as rational designs of therapeutics, that favor the formation and function of effector CD8+ T cells and overcome T cell exhaustion to treat chronic infection and cancer.